Netting prevention intervention butterfly effects: An integrative data analysis investigating the long-term and cross-over effects of randomized,school-based prevention programs on adult mental health

Project Summary
The goal of this application, submitted in response to RFA-MH-20-110, “Secondary Data Analysis to
Examine Long-Term and/or Potential Cross-Over Effects of Prevention Interventions: What are the
Benefits for Preventing Mental Health Disorders?,” is to leverage data from existing prevention
intervention trials with longitudinal follow-up to answer key questions about the long-term impacts of
prevention intervention trials. Aggregating these data sets will allow for novel secondary data analyses which
will enhance our understanding of intervention impacts on 1) suicidal behaviors, 2) depression and anxiety
symtoms and diagnoses, and 3) psychosis symptoms. There is a pressing need to link and harmonize data from
primary school universal prevention trials with longitudinal follow-up including suicide (ideation, attempt, and
death) and mental health diagnoses (including depression, anxiety, and psychosis) to understand how changing
trajectories of key risk factors for these outcomes (social support, deviant peer affiliation) prevents the
occurrence of the negative outcomes described above. Many of the existing prevention trials are not large
enough to find an impact on rare outcomes, and even less powered to explore treatment effect heterogeneity.
Our objective is to link and harmonize data from six randomized controlled trials with preventive
interventions focused on reducing disruptive and aggressive behavior in early childhood to understand
the long-term impacts of universal prevention programs on key outcomes in early adulthood including
suicidal behaviors, depression and anxiety symtoms and diagnoses, and psychosis symptoms. Data will
be utilized from the Fast Track Project (Bierman et al., 2004), the Good Behavior Game trials (Kellam et al.,
2008; Ialongo et al., 1999; Ialongo et al., 2019), the SAFEChildren Trial (Tolan et al., 2004), and the Linking the
Interests of Families and Teachers Study (LIFT; Eddy et al., 2000; Reid et al., 1999). Our hypothesis is that with
a harmonized dataset, there will be sufficient power to identify prevention program impacts into adulthood and
as such we will find impacts of these programs beyond what was originally targeted. Our rationale is that with
at least 10,000 participants across all studies, linkage and harmonizing data will allow for more complex,
multifactorial, multi-level analyses to explore intervention impact on suicidal behaviors, depression and
anxiety symtoms and diagnoses, and psychosis symptoms as well as potential mediators and
moderators of impact.

Public health relevance
Project Narrative Our objective is to link and harmonize data from six randomized controlled trials with preventive interventions focused on reducing disruptive and aggressive behavior in early childhood to understand the long-term impacts of universal prevention programs on mental health outcomes through early adulthood, including suicidal behaviors, depression and anxiety symtoms and diagnoses, and psychosis symptoms.